Institutional Career Development Core

The KL2 Core is an essential component of the Georgia Clinical & Translational Science Alliance (Georgia
CTSA) and designed to respond to the critical needs of training a new and diverse generation of clinical and
translational research (CTR) investigators who will carry out high impact research and translate new
discoveries to improve health for diverse communities. The Georgia CTSA KL2 Core is closely linked with our
TL1 Core, and both programs are governed by a joint KL2-TL1 Research Education Executive Committee. The
KL2 Core is focused on enhancing career development of junior faculty (Instructor or Assistant Professor level
with either MD, PharmD, and/or PhD degrees) with substantial potential to become successful and
transformative biomedical researchers at the Georgia CTSA partner institutions (Emory University, Morehouse
School of Medicine, Georgia Institute of Technology [Georgia Tech], and the University of Georgia). A solid
foundation has been established for the KL2 Core over the past 14 years. Our KL2 program has supported 60
scholars (including 26 during the current cycle of funding); 70% have been women (Georgia CTSA is in the top
3 hubs nationally in the proportion of women KL2 scholars) and 27% are underrepresented minorities. Among
the 46 scholars who have completed training, 43 (93%) remain in careers engaged in CTR; 70% of our former
KL2 scholars have gone on to obtain federal funding as PI; and 6 former KL2 scholars have assumed
leadership positions in Georgia CTSA. The KL2 Core also provides critical didactic and mentored CTR training
infrastructure for KL2 scholars and other trainees at the 4 partner institutions through support of the Master of
Science in Clinical Research (MSCR) program and the Certificate Program in Translational Research (CPTR).
The recent development of online/virtual training for the MSCR and CPTR programs (necessitated by the
COVID-19 pandemic) enables us to expand the reach of these successful CTR training programs across the
partner institutions. In the next funding cycle, we will expand personalized training pathways and provide
scholars with the skills to address health equity and health disparities through the conduct of CTR. We aspire
to continue to enhance diversity so that our scholars fully reflect the demography of their communities. We will
also fully implement an expanded K-ADVANCE (K to R mentoring) program for former scholars and other
trainees. A comprehensive evaluation plan will continue to measure the impact of our KL2 Core activities and
provide evidence-based data to make midcourse corrections, as needed. Specific aims include: 1) To promote
and enhance personalized career development of a diverse cadre of junior faculty at the 4 partner institutions;
2) To continue to support and innovate the successful Georgia CTSA MSCR and CPTR programs which
provide didactic and mentored CTR training to KL2 scholars and other trainees; and 3) To enhance mentorship
training and enrich “influential mentoring” activities for the next generation of CTR investigators including
culturally aware mentoring to enhance mentors’ capacity to serve in this role for a diverse group of scholars.

Public health relevance
The KL2 Core is an essential component of the Georgia Clinical & Translational Science Alliance (Georgia CTSA) and designed to respond to the critical needs of training a new and diverse generation of clinical and translational research (CTR) investigators who will carry out high impact research and translate new discoveries to improve health for diverse communities. The KL2 Core will provide didactic and mentored CTR training to a diverse group of junior faculty KL2 scholars and other trainees at the four partner Georgia CTSA institutions (Emory University, Georgia Institute of Technology, Morehouse School of Medicine, and University of Georgia). The KL2 Core also provides critical CTR training infrastructure at the Georgia CSTA partner institutions through support of a Master of Science in Clinical Research (MSCR) program and a Certificate Program in Translational Research (CPTR).